Understanding metabolic changes associated with chronic manganese exposure and Alzheimer's Disease

The etiology and pathogenesis of Alzheimer’s disease (AD) are multifactorial including genetic, environmental
and age-related factors that together drive neurodegeneration and cognitive and behavioral declines. Abnormal
molecular mechanisms impacted by chronic manganese (Mn) overexposure have been associated with
neurodegeneration and may directly contribute to and/or accelerate AD pathology and clinical dementia. Global
profiling studies using state-of-the-art analysis tools will be used to define mechanisms of exposure-induced
excitotoxity properties and to explore opportunities for intervention on altered pathways related to cognitive
function and neuropathological change in cortex and striatum brain tissue. The primary goal of this project is
to understand at the molecular level (metabolites and lipids) the biochemical mechanisms between
chronic manganese exposure and AD neuropathology. Our focus is dysregulation of glutamatergic and
dopaminergic neurotransmitter systems but the targeted and non-targeted approaches will identify multiple
novel and targetable pathways. This knowledge will be used to determine which mechanisms may potentially
be manipulated by nutrition or pharmacological interventions in order to slow cognitive decline. Our data will
also identify changes that may relate more strongly to cognitive decline than the classical hallmark features of
AD (β-Amyloid and neurofibrillary tangles). Our overarching hypothesis is that if key AD-relevant metabolic
pathways are responsive to external exposures then they are malleable and targeting these pathways may
provide new avenues to slow AD onset or progression in the brain. In the first of two independent Specific Aims
we will identify metabolomic and lipidomic changes indicative of neuropathological and behavioral change in
APP/PSEN1 mice exposed to low or high Mn through diet. We will use cortex and striatum (tissues available
through R01 ES031401) to understand changes in two areas known to accumulate Mn, that are associated
with different aspects of behavioral change. State-of-the-art chemical determination of metabolite and lipid
profiles will be used to identify which pathways are most impacted by manganese exposure, and determine if
there are differences in tissue type (striatum and cortex). Through Specific Aim 2 we will determine which
members of the glutamate metabolism pathway are dysregulated by chronic Mn exposure via targeted LC-
MS/MS analyses on the same tissues utilized in Aim 1. Specifically, these studies will allow us to determine
which specific members of the canonical glutamate metabolism pathway, as well as redox homeostasis, the
tricarboxylic (TCA) cycle and the alanine, and aspartate pathways are up- or down-regulated in response to
chronic Mn exposure to further our understanding of Mn-induced excitotoxicity in AD and normal aging brains.
All findings will be correlated with behavioral, neuropathological and biochemical data generated through the
parent R01 to interrogate functional outcomes of metabolic dysregulation.

Public health relevance
Project Narrative This project will improve our understanding of how chronic manganese-exposure affects metabolic changes in striatum and cortex tissues in transgenic mice as related to Alzheimer’s disease neuropathology. It leverages expertise in metabolomics, utilizing both hypothesis-driven and hypothesis-generating approaches combined with neurobehavioral profiling and biochemical assays. Results generated will identify critical malleable pathways that may be measured in the brain that are directly influencing neural changes.